MicroRNA-290 regulates maternal-fetal nutrient exchange during neural tube closure.

Abstract: Neural tube defects (NTDs) are among the most common and severe birth defects, affecting over
300,000 infants worldwide each year. NTDs are often lethal and, if not, lead to devastating health consequences
and early childhood mortality due to the improper development of the brain and /or spinal cord. Prevention of
NTDs is also challenging because primary neurulation begins in the third to fourth week of pregnancy, often
before a woman even knows they are pregnant. During this early pregnancy timepoint, the yolk sac acts as the
interface between the maternal and fetal environments. It supplies the growing embryo with the correct balance
of metabolites for successful growth and development. MicroRNA-290 is expressed exclusively in
extraembryonic tissues, including the yolk sac, and when knocked out, leads to a partially penetrant NTD
phenotype. However, with pregestational hyperglycemia, as a model of maternal metabolic dysregulation, loss
of miR-290 leads to increased incidences of neural tube closure defects and cellular stress in both the yolk sac
and placenta. Additionally, preliminary metabolic analysis of the yolk sac and cranial region of E10.5 embryos
reveals decreased folic acid is reaching the embryos from hyperglycemia dams. Folic acid is an essential vitamin
supplied from the maternal diet, and deficiency is known to contribute to NTDs; however, precisely how folate
prevents NTDs is unclear. We also found decreases in antioxidant glutathione and increased methyl donor SAM
in the miR-290 KO embryos, likely exacerbating the metabolic dysregulation caused by maternal stress. Folic
acid, SAM, and glutathione are all part of one-carbon metabolism, a series of interlocking, essential metabolic
cycles that provide methyl groups for numerous cell functions, including lipid synthesis. DNA and protein
methylation, and production of antioxidants. Therefore, we hypothesize that miR-290 protects
extraembryonic tissues from metabolic dysregulation by regulating one-carbon metabolism. We aim to
build off our preliminary metabolic results to establish a mechanism by which defects in extra-embryonic tissue
metabolism drive transcriptional changes in the neuroepithelial cells, impeding neural tube closure. We plan to
investigate how maternal metabolic stress impacts the yolk sac function, leading to impaired fetal central nervous
system development, and to identify strategies that can be implemented before and during the earliest pregnancy
time points.

Public health relevance
PROJECT NARRATIVE Maternal hyperglycemia increases the risks of neural tube defects and neurodevelopmental disorders. Early in pregnancy, the yolk sac and, later, the placenta supplies the growing embryo with nutrients. This proposal aims to investigate the role of miR-290, a microRNA highly expressed in the visceral yolk sac, in protecting the embryo against metabolic dysregulation during neural tube closure.